Effects of Early-life Cannabinoid Exposure on Prefrontal Circuitry and Cognitive Behavior across Development

PROJECT SUMMARY
Cannabis consumption during pregnancy and lactation has reached 7-15% in pregnant women and nursing
mothers in recent years, and will likely rise due to widespread legalization. Increased availability of cannabis has
led to the public perception that it is a safe natural remedy for pregnancy-related ailments and postpartum mood
disorders. Yet, growing clinical and preclinical data suggest prenatal and perinatal cannabis exposure is
associated with long-term neurodevelopmental consequences in children, including sensorimotor, emotional,
and cognitive deficits, as well as increased risk for illicit drug use in adolescence and adulthood. The neural
mechanisms and sensitive periods underlying these long-term effects are still poorly understood, making it
challenging to provide accurate medical advice for risk assessment of cannabis use in mothers. To address this
challenge, our overall goal is to identify the developmental processes and circuit-specific mechanisms
underlying the effects of early-life cannabinoid exposure on the emergence of cognitive behaviors. We
will focus on the medial prefrontal cortex (mPFC) due to its high levels of cannabinoid receptor expression during
development, and its critical role in cognitive processing. We will assess the circuit and network effects of early-
life exposure to the two most widely used and frequently combined cannabinoids, 9-tetrahydrocannabinol (THC)
and cannabidiol (CBD), in mouse pups across development. We will test the central hypothesis that early-life
cannabinoid exposure disrupts mPFC maturation by interfering with network synchronization during a
critical developmental window, resulting in abnormal neuronal activation during cognitive behaviors in
adolescence and adulthood. We will leverage our novel longitudinal 2-photon imaging technique in developing
mice to assess the impact of THC, CBD, and THC+CBD exposure through three aims. In Aim 1, we will reveal
the spatial and temporal patterns of in vivo network activity and eCB dynamics across development and
determine critical windows during which altered eCB signaling affects these network dynamics. In Aim 2, we will
assess how early-life THC, CBD, or THC+CBD exposure impacts eCB and calcium dynamics during
development using longitudinal 2-photon imaging. We will also examine the effects of cannabinoid exposure on
synaptic connectivity and the balance between excitation and inhibition in the mPFC. In Aim 3, we will assess
the impact of early-life cannabinoid exposure on the neural correlates of cognitive behaviors in the mPFC across
adolescence and adulthood. We will also systematically assess the behavioral outcomes after early-life
cannabinoid exposure longitudinally across neonatal, adolescence and early adulthood. Together, outcomes of
this project will identify neural mechanisms underlying later-life behavioral deficits as a result of early-life
cannabinoid exposure. As such, this project is expected to have a significant translational impact on clinical
efforts to provide guidelines on cannabis use in mothers and timely interventions for affected children.

Public health relevance
PROJECT NARRATIVE Exposing the immature brain to cannabinoids can have detrimental long-lasting consequences by interfering with normal neurodevelopment, and emerging evidence from clinical and preclinical studies suggests an association between early-life cannabinoid exposure and cognitive abnormalities. In this proposal, we will investigate the neural mechanisms underlying the consequences of early-life cannabinoid exposure. The outcome of this proposal will reveal the developmental processes and sensitive periods of cannabinoid exposure, and significantly contribute to clinical efforts for risk assessment and timely interventions.